Mechanotransduction Control of CNS Myelin Sheath Length.

Project Summary
Loss and changes to central nervous system (CNS) myelin architecture are prevalent in neurological
conditions across the lifespan. Incomplete restoration of myelin sheaths, as seen in multiple sclerosis,
leads to disability. Our long-term goal is to identify developmental mechanisms controlling CNS myelin
formation essential to CNS function, thus informing future therapies that remediate lost and aberrant myelin
in neurological diseases. Myelin sheath architecture, particularly length, controls axonal signaling speed.
The >10-fold variation in myelin sheath lengths observed in the CNS adjusts neuronal signaling speeds
and, therefore, is thought to enable neural network coordination. Considering this pivotal role for myelin
sheath length, a critical question arises: how can appropriate myelin sheath lengths be restored after
disruption in neurological disorders to faithfully enable neural networks? The objective of this proposal, to
determine mechanisms that establish CNS myelin sheath lengths, is paramount to addressing this
question. Contrasting the long-held hypothesis that biochemical instruction from neurons is required for
CNS myelination, our team made the unprecedented discovery that diameter of synthetic axons (a.k.a.
microfibers) is sufficient to control oligodendrocyte myelin sheath length. These findings led to a new model
for myelin formation and to our central hypothesis: axon diameter is a primary instructive cue that
establishes CNS myelin length, triggering oligodendrocyte mechanotransduction (i.e., how physical cues
are translated into molecular responses) mediating myelin growth. Based upon our preliminary data, we
propose that oligodendrocytes respond to the physical cue of diameter (1) via a mechanosensitive ion
channel, (2) triggering Ca2+ signaling, and (3) that diameter-triggered mechanotransduction coordinates
translational machinery essential to promote myelin sheath growth. We experimentally test this model using
complementary approaches: primary oligodendrocyte-microfiber cultures, ex vivo slice cultures, and
traditional in vivo tissue analysis. We combine our innovative oligodendrocyte-microfiber cultures with live
timelapse imaging and photomanipulation methods that allow us to both observe and manipulate signaling
within individual myelin sheaths formed by single oligodendrocytes. This uniquely enables us to assess
signals triggered solely by diameter during myelin formation with spatial precision—at the level of individual
myelin sheaths–and experimentally interrogate current proposed models for how each myelin sheath
independently controls sheath growth/elongation. Identifying mechanotransduction signals that establish
myelin sheath length in this proposed project will lay the groundwork to directly test the impact of altered
myelin lengths on CNS function that will inform strategies for myelin restoration in neurological disorders.

Public health relevance
Project Narrative Restoring coordinated, rapid neuronal signaling is a goal of myelin repair therapies in diseases such as multiple sclerosis, where myelin sheath loss leads to disability. Here we combine innovative 3-D myelinating cell cultures and in vivo analysis to identify developmental mechanisms that establish myelin sheath properties expected to enable precise neuronal signaling. Results from this work will reveal fundamental cellular and molecular mechanisms as a step towards the goal of devising strategies to restore myelin for fidelity of neuronal signaling in neurological disorders.